Morning Light Treatment for Inflammatory Bowel Disease: A Pilot Clinical Trial

ABSTRACT
Inflammatory bowel disease (IBD) is a disabling chronic inflammatory condition that includes two subtypes,
ulcerative colitis (UC) and Crohn’s disease (CD). IBD causes gastrointestinal symptoms such as abdominal
pain, rectal bleeding, and diarrhea, and extraintestinal symptoms such as sleep and mood disturbances. IBD
affects over 3 million Americans and has a relapsing and remitting course with up to 50% of patients
experiencing exacerbations each year. Immune targeted therapies such as biologics help control IBD, but
patients continue to suffer from high rates of suboptimal disease control and extraintestinal symptoms such as
fatigue, depression, and impaired quality of life. An urgent need exists to develop adjunctive treatment
approaches to better manage IBD symptoms and disease activity, which have minimal side effects, and are
readily available and affordable. Circadian disruption (disruption of the “body clock”), is proinflammatory,
worsens intestinal function, and is associated with increased disease activity, worse gastrointestinal and
extraintestinal symptoms and impaired quality of life in IBD. Thus, circadian disruption may be an important
modifiable treatment target for IBD. Morning light treatment, which advances (shifts earlier) and stabilizes
circadian timing, may have potential to improve symptoms and disease severity in IBD. However, no studies
have explored the potential therapeutic benefits of morning light treatment for IBD. Recently, we tested a 4-
week, 1-hour daily morning light treatment in individuals with fibromyalgia (R21NR016930), using a
commercially available wearable light device. We found the morning light treatment was feasible, reliably
advanced and stabilized sleep timing, and significantly improved depression, sleep quality and quality of life (all
p≤0.02), all with minimal side effects. Encouraged by this success, we propose to test the same morning light
treatment in individuals with IBD, in response to PAS-20-160: Small R01s for Clinical Trials, which does not
require preliminary data. Sixty-eight individuals with biopsy-proven IBD, clinically active disease and impaired
IBD quality of life will be randomized to 4 weeks of morning light treatment (1 h/day) or 4 weeks of treatment as
usual (TAU), with equivalent study contact in each group (completed sample n=50). Patient-reported outcomes
(IBD quality of life, mood, sleep), clinician-rated disease severity, and a biomarker of gastrointestinal
inflammation (fecal calprotectin) will be assessed before and after treatment. Aim 1 will determine the effect of
morning light treatment versus TAU on patient-reported outcomes and Aim 2 will determine the effects on
clinician-rated disease severity. We will also explore the effect of morning light treatment versus TAU on a
biomarker of gastrointestinal inflammation (fecal calprotectin), and the potential moderating effects of steroid
use, restless leg syndrome and biological sex. This project will be the first to test morning light treatment in
people with IBD, and results will provide a foundation for developing morning light treatment as a novel non-
pharmacological adjunctive treatment with potential to enhance existing treatment outcomes for IBD.

Public health relevance
NARRATIVE Novel adjunctive treatments for inflammatory bowel disease (IBD) that can better manage gastrointestinal and extraintestinal symptoms, disease activity and improve quality of life are needed. Disruption of the biological (circadian) timing system worsens both gastrointestinal and extraintestinal symptoms and reduces quality of life in IBD. This pilot clinical trial will test the potential benefits of morning light treatment (to reduce circadian disruption) on symptoms, disease severity and intestinal inflammation, and results will provide a critical foundation for the potential development of morning light treatment as a safe, non-pharmacological adjunctive treatment for IBD.